Engineering bacterial multicellular structures for therapeutic applications

PROJECT SUMMARY
The long-term goal of this R35 research plan is to define the engineering principles to rationally design
programmable bioengineered multicellular structures (ProBioMS) in prokaryotic cells. Modeled after natural
probiotic strains, ProBioMS are promising probiotic-based therapeutics. Naturally aggregating into multicellular
structures, probiotic strains exert a curative effect because they colonize specific bodily compartments and
remain viable over time. By designing their engineered principles, ProBioMS can use a variety of existing
probiotics and reach the macroscale, thus enabling the development of novel treatments such as anticavity
pastes, vaginal creams, and wound dressings. To design effective therapeutic strategies, the most critical aspect
of ProBioMS assembly is the regulation of their size, as it determines tissue adherence and the clearance rate
from bodily cavities. ProBioMS are formed by genetically engineering cells to display self-assembling binding
peptides that mediate cell-cell interactions. The strength of peptide self-assembling on the cell surface will
determine the degree of intercellular interactions and, thus, the size of ProBioMS. The genetic tools currently
available for de-novo ProBioMS design only allow for their assembly on the microscopic scale, thus limiting the
applications this technology can support. Preliminary findings from the PI demonstrate that surface-displayed
peptides that form multivalent interactions allow for macroscopic ProBioMS assembly. This interdisciplinary five-
year research plan is centered on the hypothesis that multivalent interaction-forming peptides can be leveraged
to control the size of ProBioMS over several length scales, from a few cells to the macroscopic scale. This
proposal is articulated around three main broad projects. The first effort aims to discover and characterize novel
genetic tools to assemble ProBioMS. For this purpose, we will initially focus on a subset of peptides with different
degrees of self-assembly. The characteristics observed in this first subset of peptides can be leveraged in the
future to identify additional peptides able to mediate the formation of ProBioMS with a defined size. A second
project will uncover the design rules of cell surface display to control the density of peptides on the cell surface.
This project will also add quantitative information to the under-characterized display mechanisms. Ultimately, we
will define innovative experimental methods and a computational framework for generating the engineering
principles that govern ProBioMS size, and, in the future, transfer these principles to relevant probiotic strains to
design tailored therapeutics. Overall, this MIRA proposal is significant because it will generate novel genetic
tools and engineering principles that can be applied to virtually any probiotics, enabling biomedical applications
targeting a variety of bodily compartments and diseases. This R35 program supports the mission of NIGMS on
engineering and technology development. It also broadly aligns with the NOSI “Synthetic Biology for Biomedical
Applications - NOT-EB-23-002” because it lays the foundation for creating a new class of biological materials
made of living cells.

Public health relevance
PROJECT NARRATIVE Probiotics are economical, easy to produce, and have minimal side effects, thus making them a more accessible and affordable treatment than many pharmaceutical drugs. Programmable bioengineered multicellular structures (ProBioMS) in bacteria represent an exciting new technology that can be leveraged to design potent probiotic- based therapeutic strategies. Towards this end, this proposal seeks to establish engineering principles and novel genetic tools to control the size of ProBioMS for further development of this technology as therapeutics.